Dissecting the neural circuits of maternal behaviors

SUMMARY STATEMENT
Across mammalian species, maternal behavior is an innate social behavior essential for the
survival and success of the offspring. Decades of research has identified an evolutionarily
conserved hypothalamic area, the medial preoptic area (MPOA), as being essential for the
expression of maternal behavior. However, given that the MPOA contains heterogeneous and
multifunctional cells, the identity of cells relevant for maternal behavior remains unclear.
Recently, using a series of state-of-art functional manipulation and in vivo recording tools, we
found that cells in the MPOA that express the estrogen receptor alpha (Esr1) are necessary,
sufficient and naturally active during maternal behaviors. Our proposed study will expand on
these essential findings by seeking to further investigate the neural circuits extended from the
population. In Aim 1, we will combine retrograde and antegrade tracing and in vitro slice
electrophysiology to identify the downstream targets of the MPOA Esr1+ cells in female mice. In
Aim 2, we will employ optogenetic and pharmacogenetic tools to address the functional role of
each MPOA pathway and its related downstream cells in driving various components of
maternal behaviors. In Aim 3, we will use in vivo optical and electrophysiological recordings to
examine the natural responses of cells in the MPOA downstream regions during maternal
behaviors, and the principles that underlie the transfer of information from the MPOA to its
downstream cells. This project addresses a basic question in neuroscience regarding how
maternal behavior is generated and is relevant for understanding and treating a defective
maternal circuit that causes abnormal maternal behaviors, such as child neglect and abuse.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Maternal behavior is essential for the survival of a species and the health of offspring. Our study seeks to understand the neural circuit underlying the expression of mammalian maternal behaviors by using mice as an animal model. The findings will improve our understanding of the defective maternal circuit that causes abnormal maternal behavior, potentially resulting in child neglect and abuse.